Molecular probes for allele-specific interdiction of K-Ras G12D signaling

Project Summary/Abstract
Single amino acid activating mutations at G12, G13, or Q61 are known to impair the intrinsic GTPase activity of
K-Ras which leads to its constitutive activation to drive tumor development and growth. Consequently, inhibition
of K-Ras signaling offers an attractive strategy for therapeutic intervention in cancers. Apart from small molecule
covalent modifiers of K-Ras G12C, efforts to develop reversible small molecule antagonists of K-Ras mutants
have been unsuccessful due to the intractable nature of K-Ras proteins to reversible small molecule binders.
Conversely, high affinity antagonism of K-Ras mutants have been demonstrated with antibodies and designer
binding proteins. In particular, the 7-kDa protein R11.1.6 was recently shown to antagonize K-Ras G12D
signaling when overexpressed relative to the amount of K-Ras G12D in cells. However, no inhibition was
observed in more relevant cancer models where the intracellular concentration of R11.1.6 was insufficient to
outcompete the high local effective molarity of K-Ras G12D–Raf interaction. Such stoichiometric bottleneck, in
theory, could be overcome through exogenous administration of R11.1.6 to cells harboring K-Ras G12D.
Furthermore, inhibition by degradation of K-Ras G12D could also circumvent the need for high intracellular
concentration of R11.1.6. I will test the hypotheses that exogenously delivered R11.1.6 or an R11.1.6-derived
chimeric degrader can circumvent the stoichiometric bottleneck to produce an effective antagonism of K-Ras
G12D–Raf interaction. To test these hypotheses, I will prepare protein–small-molecule chimeras of R11.1.6 as
probes to evaluate the efficiency of cellular internalization, de-esterification, functional engagement, and
catalytic degradation of K-Ras G12D. The chimeric probes will be obtained through N-terminus conjugation of
small-molecules to R11.1.6. Carboxyl groups in the resulting chimeras will be esterified with a tuned diazo
compound, which should enable the chimera to enter the cytosol of human cells. The consequences of the
chimeric probes will be assessed in relevant cell lines. The work proposed in this fellowship will be performed in
the Raines laboratory at MIT and will provide me with world-class training in chemical biology. The training under
this project also includes plans for applicant’s career development through a course in cancer biology, a teaching
certification program, and attending scientific conferences. Overall, I anticipate that the proposed work in this
fellowship will help further the mission of the NCI Ras initiative to explore new therapeutic approaches for Ras-
driven cancers.

Public health relevance
Project Narrative Recently, the 7 kDa protein R11.1.6 has been shown to be a potent allele-specific antagonist of K-Ras G12D–Raf interaction when overexpressed relative to the mutant protein, in cellulo. However, intracellular expression of the R11.1.6 was ineffective to overcome the high local effective molarity of K-Ras G12D–Raf interaction in more relevant cancer models, where the amount of intracellularly expressed R11.1.6 is insufficient to outcompete K-Ras G12D–Raf interaction. Herein, I propose to prepare esterified R11.1.6 and a R11.1.6-derived chimeric degrader of K-Ras G12D as a means to overcome the stoichiometric bottleneck in functional antagonism of K-Ras G12D–Raf interaction.